Hispanic Role Models in Health Care Careers

DESCRIPTION (provided by applicant): Hispanic Role Models in Health Careers: Empowering Hispanic Nurses to Leverage Traditional Spanish language and New Social Media to Inspire the Next Generation of Culturally Diverse and Competent Health Care Professionals The National Association of Hispanic Nurses (NAHN), in association with the Hispanic Communications Network (HCN), proposes to address the shortage of bilingual professionals in all health fields by recruiting and interviewing bilingual role models and arranging to broadcast those interviews nationwide. Leveraging HCN's nationally broadcast health education radio shows, whose cumulative audiences are larger than NPR's All Things Considered, this project has the potential to reach one out of every three US Hispanics during its first five years. This media campaign is intended to inspire Hispanic parents to encourage their children to study science and aspire to careers in the biomedical professions. It is also intended to inspire and empower Spanish-speaking adults from all walks of life to consider careers in the health professions. All broadcasts will tie to NAHN's interactive website so that students and adults interested in changing careers can find mentors and educational resources. NAHN will also use YouTube, Facebook, mobile phone applications, and other new and popular social media technologies to reach a broad cross-section of English speaking youth and young adults. In addition to the national media outputs, attendees at NAHN's annual conferences will have the opportunity to receive training in public speaking and media relations so they can more effectively use local media in their own communities to address health disparities and promote careers in the biomedical and health professions. NAHN will develop a standardized, bilingual Toolkit for public presentations. The Toolkit will include a Powerpoint presentation embedded with video containing gender- and other- stereotype-busting role model interviews with Hispanic nurses; links to an online database of volunteer mentors; and a bilingual terminology packet that will aid nurses in creating linguistic and cognitive bridges between audience and professional knowledge bases. We expect that the refined Toolkit will empower nurses and other health professionals to become more effective public health educators and career role models during their presentations at community health events, career fairs, achievement clubs, and school assemblies. An Advisory Committee of other health organizations, professionals, and advocates will recommend Role Models and provide periodic feedback. Bilingual independent evaluators associated with the UC Berkeley School of Public Health will conduct qualitative and quantitative formative, iterative, and summative evaluations throughout the project. Their recommendations and findings will be incorporated into the project design and deliverables and shared with relevant fields.

Public health relevance
PUBLIC HEALTH RELEVANCE (provided by applicant): Hispanic Role Models in Health Careers, a collaboration of the National Association of Hispanic Nurses (NAHN) and Hispanic Communications Network (HCN), addresses the need for cultural and linguistic diversity among health professionals. HCN will broadcast interviews of Role Models on its 250 affiliated Spanish-language popular radio stations nationwide to inform Spanish-speakers about the range of health careers open to them with proper education and to inspire them to imagine themselves as successful professionals. This effort will be combined with the creation of a number of bilingual online resources for health career aspirants, including an extensive database of volunteer professionals who have said "Si!Sere Mentor!" ("Yes! I will mentor you!"), which will provide Hispanics of all ages and walks of life with the opportunity to form relationships with seasoned professionals.